Modulation of pressure overload in chronic animal and in vitro models to elucidate associated effects on hemodynamics and left ventricular plasticity

PROJECT SUMMARY
Cardiac remodeling with loss of left ventricular compliance, impaired filling, and diastolic dysfunction can be
secondary to several conditions, including restrictive cardiomyopathies and pressure overload (i.e., aortic
stenosis or hypertension). Currently, there is an absence of in vitro and in vivo models of loss of LV compliance
and impaired filling representing a major barrier for the development of effective treatments. To date, no validated
in vitro model of the biomechanics of loss of LV compliance exists and animal models are limited by high mortality
rates and an inability to finely control the degree and dynamics of induced pressure overload.
The lack of robust animal models of loss of LV compliance and diastolic dysfunction has hampered the general
understanding of the pathophysiology of these conditions. As a result, there are no available strategies
that treat the underlying biomechanical manifestations of diastolic function. There is a lack of insight
into optimal intervention planning to target and reverse adverse remodeling due to pressure overload.
Through this proposal, we aim to leverage tunable dynamic mechanical implants to create disease models
of loss of LV compliance and to characterize the plasticity of LV remodeling processes from
biomechanical and hemodynamic standpoints, their progression, and potential reversal.
We recently developed a soft robotic aortic sleeve to recapitulate the acute hemodynamics of pressure overload
in a porcine model. Preliminary data show that we can re-create the hemodynamics of pressure overload and
impaired filling in an in vitro model using soft robotic tools. Here, we aim to re-create the chronic biomechanical
and hemodynamic manifestations of loss of LV compliance and impaired filling secondary to pressure
overload with an enhanced system with sensing and control abilities. Specifically, we aim to: (1) Develop
high-fidelity and patient-specific benchtop models of pressure overload loss of ventricular compliance, and
impaired filling using tunable soft robotic tools ; (2) Optimize the aortic sleeve for chronic studies through the
development of a minimally invasive delivery approach, MRI-safe implantable system, and built-in smart sensing
for closed-loop feedback control to re-create patient-specific disease and (3) Develop and evaluate a clinically
relevant chronic large animal model of cardiac remodeling due to pressure overload for time-varied degrees of
pressure overload and assessment of potential for disease regression.
Our proposed work will address limitations with current models to enable studies of the reversibility of the
remodeling processes associated with chronic pressure overload, provide insights into the
pathophysiological mechanisms, guide the optimal type and timing of intervention, and ultimately serve
as a tunable, high-fidelity, and patient-specific platform for training purposes, device development, and
hemodynamic outcome prediction for interventional planning in the clinic.

Public health relevance
Project Narrative In this proposal, we aim to recreate enhanced in vitro and in vivo models of cardiovascular disease leading to stiffening of the heart wall and its inability to fill with enough blood, eventually causing heart failure. We will use smart devices with sensing and control to induce pathological changes in the heart to help to understand disease mechanisms, and test personalized therapies for preventing or reversing the disease for the several million people suffering from this disease worldwide.